Towards Single-Molecule Protein Sequencing with Nanopores

Title:
Towards Single-molecule Protein Sequencing with Nanopores
Abstract:
This proposal concerns the development of a nascent single-molecule proteomics technology
based on nanopore sequencing. In recent work by Brinkerhoff et al., we demonstrated a first-of-
kind method for sequentially reading single peptide molecules with a biological nanopore,
detecting single-amino acid substitutions in individual molecules and showing that extremely high
fidelity may be reached through indefinitely many independent re-reads of individual proteins. This
method does not require chemical labeling of amino acids, can be carried out on commercially
available nanopore sequencing hardware, and retains the properties that enabled the success of
nanopore DNA sequencing: low overhead cost, physical rather than chemical sensitivity to small
changes in single molecules, and the flexibility to be re-engineered to target specific sequencing
applications. In this proposal to fund a collaboration of the Gundlach and Dekker laboratories,
both world leaders in nanopore technology development, we aim to develop this promising new
technology into a fully fledged single-molecule proteomics tool. This will involve characterizing
reads of a broad array of protein sequences, optimising core elements of the sequencing
methodology for protein analysis, preparing natural peptides for reading, and determining the
method's applicability to pressing proteomics problems such as post-translational modification
and splice variant detection. Achieving these aims will position the nanopore protein reader for
immediate application to proteomics problems in fundamental biology and clinical medicine.

Public health relevance
Project Narrative: This project concerns the development of a nanopore-based single-molecule protein reader, building on promising initial results showing single-amino acid sensitivity at the single-molecule level at extremely high fidelity. We aim to make key developments turning this concept into a technology with direct applications in fundamental biology and the clinic.